Processing Multiomic Datasets for Improved AI/ML-readiness in Congenital Heart Disease Research

PROJECT SUMMARY/ABSTRACT:
This Supplements application is submitted in response to the NOSI focused on improving the AI/ML-readiness
of NIH-supported data. Background: The overarching goals of the parent RCMI U54 grant Center
(U54MD007601) entitled “Ola HAWAII” are to lead and advance minority health and health disparities research
in Hawaii and beyond. The U54 Center Ola HAWAII projects aim to enhance institutional capacity to facilitate
basic biomedical, clinical and behavioral research (Aim 1); address health disparities and health-related
concerns of underserved communities (Aim 2); mentor and support a diversified health disparities research
workforce (Aim 3); and to enhance the quality and productivity of health disparities and health-related research
through world-class research facilities and services (Aim 4). This Supplements project specifically targets
cardiovascular disease (CVD), which is not only the leading cause of death globally, it also disproportionately
affects underrepresented minority populations, including Native Hawaiian and other Pacific Islanders (NHOPI).
Congenital heart defects/diseases (CHDs) are a major cause of premature death or lifelong disability, afflict ~1%
of live birth on average, and are significantly more common in Hawaii. In addition, different forms of CHDs have
varied rates across races/ethnicities. With the increasing health records and various genomics data now
available to the public, it is possible to perform a comprehensive analysis on the genetic traits of CHDs. The
scientific and public health values of big biomedical data can be boosted by data-driven technologies, such as
artificial intelligence and machine learning (AI/ML). Overall goals and aims: With this collaborative initiative on
data sciences and cardiovascular research, we propose to improve NIH-supported datasets for AI/ML
applications, including those from the Pediatric Cardiac Genetics Consortium (PCGC) and Gabriella Miller Kids
First programs. This proposal will address the critical areas in AI/ML-readiness of complex phenotype-omics big
data usage, making them FAIR (Findable, Accessible, Interoperable, and Reusable). First, we will perform
sequencing data cleaning and imputation, normalization, feature annotation and extraction, to produce
combined datasets allowing for AI/ML-ready investigation into all available PCGC/Kids First CHD samples. We
will curate the data to allow for direct and broad AI/ML-powered investigation on CHD. Then, we provide an use
case integrating the reprocessed and synthesized datasets of CHD phenotypic and molecular profiles, and
perform supervised genetic classification of cardiac defects with different ML methods. This will lead to new
genetic classifications of multifaced, mild to severe CHDs. Impacts: The processed data will be available to the
scientific community, allowing for broader AI/ML-powered data science and biomedical and clinical investigation.
The new CHD genetic classifications will provide novel therapeutic targets. And the parent U54 program will
benefit from these datasets; the new AI/ML-based discoveries of CHD genetic classifications will be a crucial
reference for our research and training efforts to advance minority health and health disparities in CVD.

Public health relevance
PROJECT NARRATIVE: In this project, we aim to improve the AI/ML-readiness of the NIH-supported multidimensional large and complex datasets for congenital heart disease research. We will reprocess the available data and apply machine learning algorithms to model and classify gene mutations associated with different forms of congenital heart defects that show varied prevalence among different races/ethnicities. The project will generate enhanced data sources for AI/ML applications, and advance our knowledge of the molecular basis of congenital heart diseases that are a major cause of premature death or lifelong disability.